CSUSM Bridges to the Future

DESCRIPTION (provided by applicant): The North San Diego County Bridges to the Future program will prepare racial and ethnic minority students for professional research careers in the biomedical sciences. The partner institutions are California State University San Marcos (CSUSM), Palomar College, and MiraCosta College. The Bridges Program will focus on the seamless transfer of partner community college racial and ethnic minority students to CSUSM and every effort will be made to integrate them into one of several MORE Program initiatives currently in operation. These initiatives are all designed to assist Bridges Scholars in completing their B.S. degrees and eventual admission to graduate programs around the country. The Bridges Program will involve 20 first and second year students each year at the partner community colleges in an integrated academic and career development program that includes: 1) participation in a rigorous curriculum; 2) Supplemental Instruction in selected historically difficult courses; 3) summer course work; 4) participation in seminars and conferences; 5) enrolling in an upper-division CSUSM course in Biomedical Research; 6) research participation; 7) comprehensive academic and career advising; and 8) participation in a vigorous tracking program. The specific aims of the Bridges Program are to: 1) Attract promising underrepresented science majors for the Bridges program; 2) Enhance the academic credentials of Bridges Scholars; 3) Engage Bridges Scholars in research; 4) Develop partnerships that support and facilitate transfer of Bridges Scholars at key points in the educational pipeline; and 5) Vigorously track all Bridges Scholars for 10 years. Each major program aim has a set of measurable objectives that will be used to monitor overall project success. The current Bridges Program is very successful averaging 90% four-year institution transfer or retention of Bridges Scholars over its first five years of operation. In addition, 10 Bridges alumni are currently pursuing PhDs. The partner institutions' commitment to diversity and multiculturalism, the pledges of significant campus financial resources, the active support of the North County High Education Alliance (NCHEA), new science and academic buildings equipped with modern scientific instruments and powerful instructional resources, the significant Bridges Scholar student pool at the partner community colleges, the success of the existing Bridges Program, the experience and commitment of the proposed program director, and the currently operating MARC U*STAR and MBRS RISE Programs at CSUSM make the partner institutions ideally situated to operate a successful Bridges to the Future program.